CORE A: Administrative Core

SUMMARY/ABSTRACT
Administrative Core
The Administrative Core (AC) is spearheading the success of the Center for Neurodegeneration and Translational
Neuroscience (CNTN). The CNTN is a multidisciplinary, thematically cohesive, mission-oriented, translational
neuroscience research program focused on neurodegenerative diseases (NDD) in Southern Nevada (NV). The
Center is a dynamic collaboration between the Cleveland Clinic Lou Ruvo Center for Brain Health (LRCBH) in Las
Vegas, Nevada (NV), and the University of Nevada Las Vegas (UNLV). Our research center is very significant for
the demographic evolution of Southern NV. This is evidenced by the fact that State Officials strongly support our
project and interact regularly with AC leadership to inquire about progress and need for support.
During CNTN Phase 1, the work accomplished by AC has transformed the translational neuroscience
research environment in Southern NV. The significant achievements of AC are: 1- the investment in cutting-edge
infrastructure for neuroscience and NDD research; 2- the mentoring of six Junior Investigators (JIs) who
graduated with independent positions; 3- the creation of a Clinical and Translational Research Core (CTRC) to
build and deeply phenotype a new longitudinal cohort of patients suffering NDD; and 4- the establishment of a
Data Management and Statistics Core to securely store and manage large biomedical datasets and assist CNTN
investigators with statistical analyses. AC has utilized the data compiled from innovative methods developed by
the Assessment Unit to monitor the operations of CNTN Cores and projects.
For Phase 2, the AC intends to exploit the data from the Assessment Unit for decision-making. The data will
be scrutinized to strategize on how to optimize the development of research infrastructure that will support new
projects, the career development of CNTN investigators, and sustainability beyond the COBRE support period.
The first step in our strategy is the augmentation of the AC leadership with two co-Directors (Drs. Sabbagh and
Kinney) and one Assistant Director (Dr. Cummings) to efficiently manage the rapid growth of the CNTN
enterprise. Our new AC leadership ambitions to accomplish five specific aims during Phase 2. First, AC will
enhance the coordination of CNTN Cores, projects, and advisory Committees. Second, the AC will advance
scientific research by increasing the size of our cohort and fortifying fundamental research projects, including
the projects by junior and pilot project investigators. Third, the AC will enhance the career development of all
CNTN personnel. Fourth, the AC will foster a robust assessment process of CNTN activities to further use the
data for decision-making. Fifth, AC will utilize COBRE, institutional, industry, and philanthropic support to
accentuate the sustainable future of neuroscience research in Southern NV. Therefore, AC leaders are fully
committed to develop the translational neuroscience research ecosystem in Southern NV and assist State
Officials with finding an impactful response to curb the upcoming NDD pandemic in NV.